Impact of chronic alcohol on neuronal cholinergic signaling

Project Summary
Alcohol use disorder (AUD) is a chronic condition characterized by escalating alcohol intake,
preoccupation with alcohol, and continued alcohol use despite adverse consequences. AUD
has broad negative health and socioeconomic impacts. AUD is linked to liver disease, birth
defects, neurological and psychological complications, weakened immune system, and heart
problems. In the US, the economic burden of AUD exceeds $220 billion annually. One facet of
AUD is persistent engagement in deleterious behaviors (e.g. alcohol consumption). The inability
to alter these behaviors may be due to chronic alcohol-induced deficits in acetylcholine (ACh)
signaling. Interestingly, ablation of ACh neurons results in AUD-like behavioral phenotypes.
Thus, the experiments proposed in this grant will examine ACh signaling in tissues obtained
from rhesus macaques with a history of long-term alcohol self-administration. In the first
experiment, the fabrication method for carbon fiber electrodes to measure ACh release will be
refined and validated for measurement of ACh release in mouse brain slices (Specific Aim 1a).
These validated acetylcholine probes will then be used in two annual necropsies at the Oregon
National Primate Research Center where we will measure ACh release in brain regions
implicated in AUD (e.g. caudate nucleus, putamen, cingulate & prefrontal cortex) from long-term
alcohol self-administering and control macaques (Specific Aim 1b). In the second set of
experiments (Specific Aim 2), we will obtain RNA samples from several brain regions from the
Monkey Alcohol Tissue Research Resource (MATRR) to compare gene expression of ACh
signaling related proteins from the same alcohol self-administering and control macaques used
in the necropsies. Altogether, the subjects from these necropsies will include male and female,
as well as, alcohol self-administering and control subjects, allowing for multifactorial analysis of
any obtained data. Further, our ACh measurements will be correlated with cognitive flexibility
measures obtained by the MATRR. Importantly, these results will fill a gap in the AUD literature
and make use of an important resource (MATRR) that provides NHP tissues from the most
relevant and translatable model of human AUD.

Public health relevance
Project Relevance Acetylcholine (ACh) is a neurotransmitter involved in cognitive flexibility, the ability to change behavioral patterns. Cognitive flexibility is reduced in alcohol use disorder patients and we believe this is mediated by deficits in ACh neurotransmission. Therefore, the proposed experiments will assess ACh transmission, and expression of ACh-related genes, in control and chronic alcohol consuming subjects.